A Novel Nitrosylase Prevents Hypoglycemia and Mediates Insulin Resistance

PROJECT SUMMARY
Nearly 1 in 10 Americans has type 2 diabetes mellitus (T2DM), and the incidence continues to rise as the US
population both grows heavier and ages. T2DM is characterized by insulin resistance, where the insulin target
tissues become under-responsive to insulin stimulation, leading to unregulated blood glucose and tissue
damage. Despite multiple therapeutic approaches to increase insulin production and to enhance insulin receptor
sensitivity, there are no drugs that directly ameliorate insulin resistance by targeting mechanisms that drive
insulin resistance, in part because these mechanisms remain poorly defined. We have identified novel machinery
that regulates S-nitrosylation of the insulin receptor (INSR) and its key downstream mediator, insulin receptor
substrate 1 (IRS1), including the enzymes SCAN and SCoR, which catalyze S-nitrosylation and denitrosylation
of INSRβ/IRS1 respectively. Under normal conditions, insulin-stimulated S-nitrosylation of INSRβ/IRS1 by SCAN
transiently inhibits signaling to prevent hypoglycemia. In obesity, sustained and excessive S-nitrosylation of
INSRβ/IRS1 by SCAN in skeletal muscle chronically inhibits insulin signaling, leading to insulin resistance.
Excessive SCAN activity and consequent hypernitrosylation of INSRβ/IRS1 are also induced by aging and by
glucocorticoid treatment, representing a widespread cause of insulin resistance. In human skeletal muscle and
adipose tissue, SCAN expression increases with Body Mass Index and correlates with INSRβ S-nitrosylation,
suggesting this mechanism is relevant to human insulin resistance. Our goal is to define the role of this novel
pair of enzymes (SCAN and SCoR) in insulin signaling and to elucidate their clinical significance. We will 1)
characterize a newly discovered S-nitrosylation-based feedback loop in insulin signaling; 2) define the
pathological role of SCAN and SCoR in insulin resistance; 3) determine the clinical significance of SCAN in
insulin resistance. Successful completion of these Aims will define the functional role of S-nitrosylation of
INSRβ/IRS1 by SCAN and SCoR in both health and disease. More broadly, our work promises both new
understanding of obesity-, aging-, and
glucocorticoid therapy
-associated T2DM and new therapeutic
opportunities for treating metabolic disorders and T2DM.

Public health relevance
PROJECT NARRATIVE Insulin resistance is a major factor in the pathology of obesity-associated type 2 diabetes mellitus. We have identified two enzymes that together control the functional state of the insulin receptor through a novel negative feedback loop, and demonstrate that this receptor inhibition is increased in obesity to drive insulin resistance. Understanding this novel mechanism regulating insulin sensitivity may allow identification of new drug targets to treat insulin resistance in metabolic syndrome and type 2 diabetes mellitus.